STUDIES ON RETROVIRAL AND CELLULAR ONCOGENES

We are pursuing our studies of oncogene involvement in neoplastic transformation and in cellular differentiation. Toward this goal, we have analyzed in vitro transformation of cell cultures and alterations of proto-oncogenes in animal and human tumors. Transformation of embryo cells in vitro by MH2 virus has been used as a model system for understanding the differential functions of the two oncogenes contained in this virus (v-mht and v-myc). A complete MH2 provirus containing all the LTR regulatory elements has been constructed by molecular genetics techniques. This provirus (L5-MH2) is now efficiently used in transfections of chick embryo fibroblasts for the production of an infectious transforming virus. Deletion mutants have been obtained from L5-MH2 which contain one oncogene only (either v-mht or v-myc). Their differential effects on chick embryo fibroblasts in vitro are an interesting correlate of the in vivo tumorigenicity of the MC-29 family of viruses. Three human proto-oncogenes homologous to avian retroviral oncogenes have been studied in animal and human tumors. While no alterations have been detected so far in the human c-mht structure, interesting abnormalities in c-myc and c-ets appear to be present in animal and human neoplasias. We have discovered amplification of c-myc in a mouse lymphoma and in a human neuroectodermal tumor. In both cases, c-myc amplification might be correlated with tumor progression more than with the onset of the disease. Alterations of the c-ets proto-oncogene might be even more interesting because of the peculiar association of viral ets with myeloid and erythroid leukemias. Rearrangements and amplification of c-ets have been discovered in human leukemias.